University of Maryland Center of Excellence in Regulatory Science and Innovation

Project Summary
We propose a 5-year renewal of the University of Maryland Center of Excellence in Regulatory Science and
Innovation (M-CERSI), a consortia of the two leading sister campuses within the University System of
Maryland (USM), and the Food and Drug Administration (FDA). M-CERSI leverages the biomedical and health
outcomes strengths in Baltimore with the engineering and technologies strengths in College Park. Aims
include: Establish core program infrastructure and work plan to ensure success; Conduct cutting-edge
regulatory science research; Provide mechanisms to expand M-CERSI activities; Provide regulatory science
information sharing opportunities; and Increase access to M-CERSI opportunities to faculty, FDA scientists,
and trainees who are underrepresented in regulatory science. Proposed research projects align with FDA's
regulatory science framework to modernize development and evaluation of FDA-regulated products,
strengthen post-market surveillance and labeling of FDA-regulated products, and invigorate public health
preparedness and response of the FDA, patients and consumers. All M-CERSI research is collaborative with
FDA scientists and employs a vast array of research capabilities at the University of Maryland. Research is
accentuated by a Research Scientist Collaboration Program and a robust program of information sharing
opportunities, which includes workshops, scholars program, lectures, and the America's Got Regulatory
Science Talent Competition. The sum of these activities describes a vibrant, cutting edge Center that
stimulates innovative thought, disseminates understanding of regulatory sciences and practices, and generates
new knowledge in support of the FDA's fundamental mission – to promote and protect the public health.

Public health relevance
Narrative Statement We propose continuation of M-CERSI that fosters FDA-oriented research, as well as regulatory science information sharing opportunities. The Center's mission is to foster the development of regulatory science – the science of developing new tools, standards and approaches to assess the safety, efficacy, quality and performance of FDA-regulated products. Activities leverage the close geographic proximity between University of Maryland and FDA's main campus.